The Amyloidosis Forum: Cross Stakeholder Working Group Projects to Accelerate Drug Development in AL and ATTR Amyloidosis

Project Summary/Abstract
The Amyloidosis Research Consortium (ARC), established in 2015, is a patient-led nonprofit organization.
ARC’s mission is to build mutually beneficial collaborations between government, academia, industry,
patients, and regulatory agencies to systematically address critical barriers and challenges that slow the
development of new therapies for systemic amyloidosis. In 2019, ARC entered a public-private partnership
with the US Food and Drug Administration (FDA) known as the Amyloidosis Forum to bridge scientific gaps
in drug development for the treatment of amyloidosis. The Amyloidosis Forum seeks to leverage the
expertise and resources of diverse stakeholders for the conduct of mutually beneficial scientific activities in
the precompetitive domain to support bringing new, safe and efficacious therapies to patients with
amyloidosis.
Collaborative efforts across stakeholders and innovative approaches are essential to propel the future
development of effective therapies for multi-systemic diseases like immunoglobulin light chain (AL) and
transthyretin (ATTR) amyloidosis. The proposed conference, to be held at the FDA White Oak campus,
will provide an opportunity for prioritized working groups launched through the Amyloidosis Forum to share
their research and engage with diverse stakeholders to seek feedback and insight that will enable them to
strengthen their research. These collaborative working groups are focused on four priority areas: imaging
standardization, identification of prognostic factors, development of clinical endpoints, and accelerating
access to data-driven insights from completed trials in AL and ATTR amyloidosis. This meeting, The
Amyloidosis Forum: Cross Stakeholder Working Group Projects to Accelerate Drug Development in AL
and ATTR Amyloidosis, will aim to do the following:
Specific Aim 1: Engage diverse stakeholders to inform and strengthen working group research
strategies and projects that will address scientific and regulatory gaps required to advance drug
development.
• Critically evaluate and discuss research updates provided by the Amyloidosis Forum working
groups.
• Present diverse feedback on the design of proposed collaborative research studies.
Specific Aim 2: Provide a collaborative opportunity for stakeholders to convey their perspectives
on future priorities and research direction.
• Evaluate and align stakeholder priorities for future research projects.
Specific Aim 3: Enable early-career professionals with opportunities to network with experienced
amyloidosis researchers.
• Provide early career professionals with broad perspectives across the amyloidosis therapeutic
development spectrum and an opportunity to engage with experienced research professionals.

Public health relevance
Project Narrative Systemic amyloidoses are rare multisystemic disorders that share many features with more common geriatric syndromes, in that they are chronic and incurable conditions that are associated with acute exacerbations rather than isolated episodes of care. Despite recent progress and the approval of innovative therapies designed to slow disease progression, there remains a substantial unmet need in treating amyloidosis. The Amyloidosis Forum, a Public Private Partnership between the Amyloidosis Research Consortium and FDA, will bring together the diverse stakeholder scientific community to further progress in therapeutic and diagnostic development in ATTR and AL amyloidosis with a scientific conference that will focus on accelerated learning from completed clinical trials to inform ongoing drug development, standardization of imaging modalities, prognostic factors and endpoint development, and innovations in clinical trial design.